Elucidating the Contribution of Genetic Recombination in Treponema pallidum to Syphilis Pathogenesis

ABSTRACT
The spirochete Treponema pallidum subspecies pallidum (TP) causes syphilis, a multi-stage sexually
transmitted infection. Cases of TP are rapidly increasing in high income countries and remain persistently high
worldwide, with a total of 8 million incident cases globally each year. TP can disseminate to nearly any tissue,
leading to significant morbidity in advanced stages of disease, and can be vertically transmitted, causing
congenital syphilis. Despite its protean manifestations, TP has a minimalist genome with limited genetic
diversity and accumulates single nucleotide changes slowly. In contrast, TP readily undergoes inter-strain or
intra-chromosomal homologous recombination (HR) to generate novel variants. For example, intra-
chromosomal HR between 53 defined donor sites and seven extracellular loops of the Treponema pallidum
repeat protein K (TprK) generates novel epitopes and underlies immune escape. Additionally, we recently
examined samples from a patient with uncontrolled HIV and co-infected with two strains of TP, with HR
observed between the strains in a penicillin-binding protein and a fatty acid transporter, with unknown fitness
effects. In spite of considerable evidence that TP uses genetic recombination as a survival strategy, little is
known about mechanisms of HR in TP. Building on our published and unpublished findings, here we will
identify the TP genes involved in HR and the response to DNA damage and examine TP genomic changes
following the induction of recombination. This will be achieved via two complementary Specific Aims: In Aim 1,
we will induce DNA damage and HR directly by treatment with genotoxic agents or indirectly with sublethal
penicillin treatment. Then, we will examine longitudinal transcriptional responses to identify gene networks,
such as homologs of the SOS Response pathway, involved in HR. We will also identify putative transcription
factor binding sites among differentially expressed TP genes. In Aim 2, we will use whole genome sequencing
and targeted amplicon long-read sequencing to observe the genomic alterations caused by HR between
Nichols and SS14 strains during longitudinal co-infection in vitro and in vivo (Aim 2.1) and between TP and HR
donor plasmids following DNA damage or sublethal penicillin treatment (Aim 2.2). We will determine the TP
genes that undergo HR most frequently when supplied with donor template, focusing particularly on penicillin
binding proteins and extracellular loops of outer membrane proteins being considered for inclusion in an
eventual syphilis vaccine. This proposal makes use of simple and elegant experiments using our established
protocols for in vitro culture, rabbit infection, TP RNAseq, and whole genome and long-read amplicon
sequencing. Insights gained from these experiments will have implications for antibiotic stewardship and help
inform selection of antigens for syphilis vaccine development. Together, these studies provide crucial insight
into a previously unexplored mechanism of TP pathogenesis.

Public health relevance
PROJECT NARRATIVE Treponema pallidum subspecies pallidum (TP) causes the sexually transmitted disease syphilis, which can persist in the host to cause significant morbidity if left untreated and be vertically transmitted from mother to fetus, causing congenital syphilis. DNA recombination in TP allows adaptation via rapid genetic changes and underlies intra-host persistence, yet the mechanisms governing and conditions that drive recombination are unknown. This project will use classic microbiological approaches to induce genetic recombination in TP coupled with state-of-the-art analyses of gene sequence and expression changes, shedding light on the conditions that lead to diversification and immune escape by TP.